Hippocampal Alteration in Methamphetamine Misuse

An estimated 2.5 million adults in the United States will use methamphetamine (MA) this year and 1.6 million will meet the criteria
for MA use disorder, mostly in western and midwestern states. The national societal and economic burden of MA use is estimated
to be greater than $40 billion. The cost to the individual user’s health is also dire. MA misuse is associated with physical health
concerns such as cardiac arrhythmia and stroke, mental health concerns such as depression and psychosis, and cognitive health
concerns broadly including impairments in attention, decision making, and memory. MA-associated memory deficits are ubiquitous,
particularly hippocampal-dependent memory, and yet MA-associated brain structure changes in the human hippocampus remain
under investigated and poorly understood. Findings to date have used MRI-derived volume measures to assess hippocampal
integrity with MA misuse and results have been inconsistent. There are several reasons that may account for these
inconsistencies. First, volume is a gross measure of large-scale changes that is not sufficiently sensitive to measure microstructural
changes that may occur with MA misuse. Second, the hippocampus is a heterogenous structure with dissociable subfields that
each support different aspects of memory function. Magnetic resonance elastography (MRE) is an emerging tool for acquiring
noninvasive measures of the mechanical properties of biological tissue. By doing so, MRE provides a measure of microstructural
tissue health with sufficient resolution to assess the whole hippocampus, as well as the individual hippocampal subfields. The work
proposed in the present application will (1) assess disruptions in the microstructural integrity of the hippocampus and identify
impairments in its specific subfields with MA misuse and (2) to determine the impact of these MA-induced structural disruptions on
hippocampal-dependent memory. To address these aims, MRI/MRE scans, as well as a diverse cognitive battery of hippocampaldependent
memory tasks will be collected from MA users and a group of matched, non-substance using comparison participants.
We expect that MRE-derived measures of microstructural integrity will differ between the groups with the MA group showing
reduced integrity. We also expect that, based on findings form preclinical rodent studies, the dentate gyrus subfield will be most
strongly affected and that the MA group will be impaired on tasks of hippocampal-dependent broadly, but the deficit will be largest
for tasks that depend critically on relational information supported by the dentate gyrus. This work will establish MRE as a useful
tool for measuring changes in hippocampal integrity associated with MA misuse forming a critical foundation for the identification of
quantitative/diagnostic biomarkers for behavioral dysfunction in this population. This long-term goal of this project is to lay the
groundwork for future investigations tracking brain changes associated with prolonged use, effective interventions, and recovery
more broadly.